Developmental Funds

Building on a record of substantial recruitment, shared resource development, research advances and Developmental Cancer Research Seed Grant Awards (DCRAs) that has resulted in a more collaborative and productive environment, the Cancer Center requests $750,000 to support its further development. Developmental Funds amounting to 14% of the total Direct Costs of the Cancer Center Support Grant budget are requested for three major purposes: [unreadable] to facilitate faculty recruitment ($400,000) [unreadable] to provide seed grant support for translational and population sciences ($250,000) [unreadable] to support new and expanded shared resources ($100,000) Developmental funds will be essential to enable the leadership to contribute to the recruitment of faculty in areas established as high priority by our strategic planning process. In addition, the promotion of interdisciplinary research will require seed money for pilot grant support in areas that bring together investigators of different disciplines. Finally, the ability to integrate a developing Population Sciences Shared Resource for subject recruitment and retention and a developing Bioinformatics Shared Resource into the Cancer Center organization will require CCSG support.